Intermittent Fasting using a Fasting-Mimetic Diet to Improve Prostate Cancer Control and Metabolic Outcomes

ABSTRACT
Prostate cancer (PC) remains the most common cancer affecting men in the US, resulting in both a high
number of deaths but also an even greater number of survivors experiencing treatment-related toxicities.
Androgen deprivation therapy (ADT) is a cornerstone of therapy for both locally advanced and metastatic cases,
though it results in myriad negative effects, including increased insulin resistance and incident diabetes. The
intensified androgen receptor targeted agents (ARTA), while improving overall survival, exacerbate these
negative effects. Most men with PC are older, thus at risk of, or already suffering from, comorbidities such as
diabetes and heart disease; these often represent their greatest threat to mortality.
The ADT-induced metabolic changes may also adversely impact men at high risk of PC death by
promoting cancer progression. During ADT, insulin, leptin and IGF1 levels all increase; higher levels are linked
with more aggressive PC and may drive castration resistance. We showed in human studies that intermittent
fasting using a fasting-mimicking diet (FMD) can favorably change insulin, glucose and IGF1/IGFBPs. Our FMD
trials involved patients consuming a very low-calorie plant-based FMD for 5 days while during days 6-28, patients
ate what they wanted, but were encouraged to eat per European Society for Clinical Nutrition and Metabolism
guidelines for cancer survivors. Further, we showed this approach can delay tumor progression in multiple mouse
models including PC. Based upon the above, we hypothesize that intermittent fasting using a FMD will delay PC
progression and improve metabolic health in men being treated with intensified ADT. To test this hypothesis, we
propose a three-site randomized controlled trial of an intermittent fasting intervention using a FMD vs. standard
of care for 6 months in patients with metastatic castration sensitive PC (mCSPC) starting on intensified ADT with
or without chemotherapy. For the first time, we will test the effect of FMD on improvement in PSA nadir, an early
clinical endpoint strongly correlated with better survival. We will also measure how changes in insulin and IGF1
associate with PSA nadir as one mechanism by which this dietary approach improves cancer outcomes and will
further seek to define a molecular subset of PCs which are most responsive to this diet.
The results of this trial will have immediate impact for PC patients, both metastatic and potentially the
larger population who receive a course of ADT with definitive therapy. Thousands of men each year could be
prevented from developing or having exacerbation of diabetes and other cardiovascular risk factors, which are
their greatest mortality threat, by using a FMD. For men with metastatic PC, improving tumor control and delaying
castration resistance would reduce morbidity, particularly skeletal complications, and improve survival. The PC
research community will gain insight into metabolic toxicity and hormonal pathway interactions with the next-
generation ARTA as well as identify molecular subtypes that benefit most from intermittent fasting using a FMD.

Public health relevance
Narrative Men with metastatic castration sensitive prostate cancer (mCSPC) are at high risk of disease progression and while the treatments used can delay progression, they can increase the risk of metabolic side effects (diabetes and heart disease). Data from our team has shown that intermittent fasting using a fasting mimicking diet (FMD) can improve metabolic health in people and delay cancer progression in mice, including in prostate cancer models. We propose a phase 2 multisite randomized trial of intermittent fasting with a FMD vs. standard of care in men with mCSPC designed to improve cancer control and reduce risk of diabetes, while gaining insight into how insulin and IGF1 signaling are associated with the benefit of FMD in delaying prostate cancer progression.